Mechanism-based targeting of unique survival signaling in residual tumors

Project Summary/Abstract
The clinical activities of oncogene targeted therapies are limited by the fact that a subset of residual cancer
cells often survive treatment, eventually giving rise to progressive, resistant disease that is very difficult to treat.
To date, relatively little is known about residual disease cells, in part because obtaining and analyzing tumor
specimens at this stage has been logistically challenging. We recently discovered that residual cells surviving
treatment with diverse, oncogene-matched targeted therapies exhibit DNA double strand breaks (DSBs) and
consequent, ATM-dependent DSB repair. In mechanistic studies performed in EGFR mutant non-small cell
lung cancer (NSCLC), this DNA damage was observed to be driven by the counterintuitive “sublethal”
activation of executioner caspases 3 and 7, which drive DNA damage through their direct activation of
caspase-activated DNase (CAD). As a consequence, residual cancer cells that survive upfront EGFR inhibitor
treatment require ATM activity to resolve DSBs, and combining EGFR inhibitors with ATM inhibitors eradicates
residual cells, leading to highly penetrant and durable therapeutic responses in cellular and animal models.
These findings are further supported by our clinical observations that residual EGFR mutant lung tumors
display marked upregulation of ATM activity and that rare NSCLC patients whose tumors harbor loss-of-
function mutations in ATM exhibit increased progression-free survival on EGFR inhibitor therapy. In this
proposal, we describe studies to define the mechanisms driving sublethal caspase activation in residual tumor
cells and their consequent, ATM-dependent survival. Further, we propose to define the broad, functional
implications of sublethal caspase and ATM activation in residual tumor cells, revealing consequent mechanistic
vulnerabilities of residual tumors. Finally, we describe studies that integrate cellular, patient-derived xenograft,
and genetically engineered mouse models with highly credentialed, longitudinally sampled clinical specimens
to evaluate the therapeutic targeting of residual tumor cell survival. Together, these studies will define key,
distinguishing features of residual tumor cells, advancing our basic understanding of this critically important but
poorly understood aspect of tumor biology while defining a new class of mechanism-based strategies with the
potential to minimize residual disease.

Public health relevance
Project Narrative Targeted cancer therapies have the exciting potential to selectively kill malignant cells while sparing healthy tissues, as evidenced by their often remarkable upfront activity in patients. However, in nearly all patients, a subset of residual cancer cells survive therapy and later emerge to give rise to resistant disease that is very difficult to treat. In this proposal, we build on our recent discovery of unique biological processes related to cell death regulation and DNA repair that are activated in residual cancer cells, proposing mechanistic studies that will significantly expand our understanding of residual tumor biology while directly nominating therapeutic strategies to eliminate this critical tumor cell population.